ARID1a and Chromatin Landscape in Pulmonary Vascular Disease

PROJECT SUMMARY
Pulmonary arterial hypertension (PAH) is a rare, chronic, and progressive pulmonary vascular disease leading
to right ventricle failure and ultimately to death. Despite the available treatments and ongoing research efforts,
there is currently no curative treatment against PAH or the pathological vascular remodeling. Current
understanding of the dysregulation of chromatin in PAH pathogenesis remains limited. The SWItch/Sucrose Non-
Fermentable (SWI/SNF) chromatin remodeling complexes control accessibility of chromatin to transcriptional
and coregulatory machineries. The AT-rich interactive domain-containing protein 1a (ARID1a), a subunit of the
SWI/SNF chromatin-remodeling complex, plays important roles in normal physiology and diseases. Homeostasis
requires balanced action of ARID1a and EZH2, a histone methyltransferase, through chromatin-mediated gene
expression. Yet, the role of ARID1a in PAH remains understudied. Given the various studies implicating ARID1a
as a critical tumor suppressor, the objective of this proposal is to investigate the expression level of ARID1a and
the link between ARID1A and EZH2 in pulmonary vascular smooth muscle cells (PASMCs) growth and
dysfunction. The central hypothesis is that ARID1a loss impairs enhancer-mediated gene regulation and drives
aberrant growth of PASMC in PAH through altered chromatin accessibility and/or DNA methylation via EZH2
(Fig. 1). The hypothesis is supported by preliminary data of the downregulation of ARID1a expression level in
human and animal models of PAH. Importantly, ARID1a depletion using shRNA increased PASMC proliferation
and increased EZH2 expression. Hence, the hypothesis will be tested by pursuing the following two specific
aims: 1) Investigate the emerging roles of ARID1a in PASMC phenotype and the regulation of gene expression
through EZH2 and targeted modulation of chromatin accessibility, and 2) Evaluate the effects of ARID1a-specific
ablation in SMC and the intratracheal delivery of EZH2 inhibitors in ARID1aSMC-/- mice exposed to chronic hypoxia
and Sugen conditions. The data generated from this proposal will advance our knowledge about the role of
ARID1a in the phenotype of PASMC-driven pulmonary vascular disease, with implications for therapeutic
interventions in PAH.

Public health relevance
PROJECT NARRATIVE This proposal is relevant to public health because understanding the role of the chromatin-remodeling factor ARID1a and the mechanisms underlying the regulation of EZH2 in the lung vascular smooth cells is critical that may inform novel strategies for treatments for rare pulmonary arterial hypertension disease.